The Evolution of Sexually Dimorphic Morphogenesis

PROJECT SUMMARY/ABSTRACT
Although the processes that regulate sexual dimorphism vary between taxa, a group of genes known as DM
domain transcription factors (DMRT TFs) play a major role in the development of male-specific traits. How
these TFs are linked to morphogenetic effectors, however, is unknown. Also, it is unclear what parts of
morphogenetic regulation and its machinery are evolutionarily constrained versus plastic. Here, 4 tail tip cells
of Caenorhabditis elegans are used as a model system to address these knowledge gaps. During the last
larval stage (L4), in males only, these cells undergo Tail Tip Morphogenesis (TTM). The DMRT TF, DMD-3, is
required and sufficient for TTM. A paralog, MAB-3, also regulates TTM in a role not well understood. Also, TTM
has evolved repeatedly in nematodes, providing an opportunity to determine how conserved or evolvable is
TTM and its transcriptional regulation. The overall goal is to delineate what genes are transcriptionally
controlled by DMD-3 and MAB-3, to determine the extent of overlap in targets between these TFs, and to
determine what parts of this transcriptional control are constrained vs. plastic via interspecific comparisons.
Aim 1 is to delineate how DMD-3 transcriptionally controls TTM and how MAB-3 contributes to this regulation
(i.e. how much of MAB-3 contribution is due to overlapping vs. non-overlapping control). This will be done by
comparing transcriptome profiles of single tail tips throughout TTM from wild-type males to those from DMD-3
and MAB-3 mutants. Direct vs. indirect targets of DMD-3 will be distinguished by comparing these data to
whole-worm DMD-3 ChIP-seq data previously obtained in the lab. Aim 2 is to determine how plastic or
constrained is the regulation of TTM across different nematode species by using the same tail-tip-specific
RNA-seq approach on species in which TTM repeatedly evolved, and will identify which parts of the
transcriptome are conserved. The expected outcome is an understanding of how transcriptional regulation by
DMD-3 and MAB-3 is linked to morphogenetic effectors, what is the role of MAB-3, and what parts of the
transcriptional regulation are conserved versus evolvable. These results are expected to have a positive
impact on medicine, as they could identify key conserved genes that control particular aspects of
morphogenesis as in birth defects or cancer. Goals of the integrated training plan are to deepen knowledge,
gain skills in rigorous experimental design, hone communication skills, augment leadership and mentoring
skills, and transition toward an independent career in biomedical research. This training will be carried out
using the above research as a platform for one-on-one mentoring, as well as coursework, journal clubs,
seminars, an advisory committee, teaching experience, conferences, retention mechanisms and many other
resources. This training will occur in a nurturing, collaborative environment with state-of-the-art facilities and
equipment, high-quality NIH-supported curricula in developmental systems biology, and a proven record of
producing diverse, top-notch scientists.

Public health relevance
PROJECT NARRATIVE Morphogenesis is a universally important process that is controlled by precise spatiotemporal regulation of gene transcription (expression). Advances have been made in elucidating the cell biological machinery of morphogenesis; however, we lack an understanding of how transcriptional regulation controls this machinery, why this control is robust, and what parts of this control are conserved vs. plastic. This study will inform us about the architecture of transcriptional control of morphogenesis and how it has evolved, thus providing a basis to identify key conserved components that control morphogenesis, possibly leading to new targets for medical advances in aiding wound healing and mitigating morphogenetic errors that contribute to birth defects or cancer.